The Clock is Ticking: Epigenetic Age Acceleration as a Biomarker of Uterine Function in Pregnancy

Women of advanced age (> 35 years of age) are at significantly higher risk for adverse outcomes during
childbirth, compared to younger women. This problem is both critical and growing, as the number of births
occurring in this age group have increased nine-fold over the last 40 years, escalating maternal morbidity and
mortality in the US. Given that prolonged labor, Cesarean birth and postpartum hemorrhage are more common
among older women, a decline in uterine function (contractility) with advancing age may be a source of labor-
related dysfunction. Prior studies have shown that individuals’ biological ages often differ from chronological
(i.e. actual) ages, raising the possibility that biological age could be a better predictor of age-related perinatal
morbidity. A robust method of calculating biological age is the Epigenetic Clock, which determines an
individual’s Epigenetic Age based on their specific DNA methylation patterns (common epigenetic
modifications). Epigenetic Age has been shown to better predict morbidity or mortality over chronological age
and epigenetic aging is also associated with social adversity and stress exposure. Given that social and
economic stressors contribute to poor maternal outcomes (as evidenced by maternal health disparities), it is
possible that epigenetic age is also a key mediator of birth related morbidity. Therefore, I will test the central
hypothesis that epigenetic age will predict impaired uterine function more accurately than maternal
chronological age (years) and that greater epigenetic age is associated with higher indices of psychosocial/
socioeconomic stressors during pregnancy. The career development goal of this application is to gain
proficiency in genome wide epigenetic methods and epigenetic clock specifically in addition to expanding my
training to include health disparities research methods. In this proposal, I seek to integrate these scientific
fields and advance knowledge of the role of the environment on maternal health and morbidity related to
childbirth and uterine function. In the first aim, using bio-banked tissues, I will apply Epigenetic Clock methods
to extracted DNA from maternal uterine and blood samples to compare epigenetic age across tissue types and
correlate with uterine mRNA for proteins responsible for uterine contractility and function during labor. In the
second aim, I will use banked data and tissue from a large nationally representative sample of young (18-25
yo) and advanced age women (>35 yo). I will apply the Epigenetic Clock method to these DNA samples to 1)
understand the relationship between phenotypes of socioeconomic and psychosocial stress (using mixture
modeling) and epigenetic age in maternal blood and 2) examine the role of epigenetic age and uterine
dysfunction during labor leading to greater maternal morbidity (prolonged labor leading to cesarean delivery,
failed induction or postpartum hemorrhage). Finally, I will explore how maternal epigenetic age relates to
infants’ gestational age and his/her own epigenetic age. Together, this study will advance our knowledge of
how epigenetic aging can influence perinatal morbidity in the context of the maternal environment.

Public health relevance
Project Narrative Maternal health disparities, uterine dysfunction and childbirth-related morbidity are associated with maternal aging; however, individual morbidity linked to aging is better predicted by epigenetic age, a measure of biological age. My research will leverage a robust biomarker of aging, Epigenetic Clock, to understand how a woman’s epigenetic age relates to both uterine function/dysfunction during birth and her self-reported burden of psychosocial and socioeconomic stress during pregnancy. This work will shed critical light on the complex integrated relationship between social and physical environmental exposures and biological changes that underpin maternal health disparities.